Neisseria gonorrhoeae metal transporters that subvert nutritional immunity

The human-specific bacterial pathogen Neisseria gonorrhoeae (Ngo) causes the sexually-transmitted infection
gonorrhea. Ngo expresses outer membrane transporters to acquire iron and other metals in a TonB-dependent
manner. In order to prevent microbial growth and infectivity, humans use high affinity metal-binding proteins to
sequester essential metals, a phenomenon known as “nutritional immunity.” Ngo subverts nutritional immunity
by using dedicated TonB-dependent transporters (TdTs) that bind to and remove the metals from human metal-
binding proteins such as transferrin and lactoferrin, which sequester iron (Fe). Our preliminary data indicates
that two Ngo outer membrane transporters, TdfH and TdfJ, enable Ngo to internalize zinc (Zn) from Zn-
sequestering, human innate immunity proteins. TdfH affords Ngo the ability to overcome Zn sequestration
imposed by the innate immunity protein calprotectin (CP), which is produced in abundance by neutrophils and
accumulates to high concentrations at sites of inflammation. Furthermore, in the prior funding period, we
determined that TdfJ enables the use of S100A7, also known as psoriasin, as the sole Zn source. Two other
transporters, TdfF and TdfG, are not as well defined, but their expression is iron-repressed. We hypothesize
that these metal transporters enable Ngo to overcome the growth inhibitory effects of the innate immunity
proteins produced during inflammation. These studies are significant because knowing how Ngo acquires
essential metals like Zn and Fe from the human host opens new opportunities for developing new therapeutics
against ‘superbug’ strains, whether they be targets for a protective vaccine or small molecule inhibitors of crucial
transporters. The overarching hypothesis to be tested in the proposed study is that Ngo subverts nutritional
immunity imposed by host metal-chelating proteins including S100 proteins, which are produced by neutrophils
and epithelial cells, by the deployment of outer membrane transporters, which bind to and relieve these proteins
of their sequestered transition metal cargo. To test these hypotheses, the following specific aims are proposed:
Aim 1 will interrogate the metal environment sensed by Ngo when interacting with human cervical cells and
primary human PMNs, cell types important in human infection. We will identify the infection conditions under
which Ngo experiences Fe and Zn limitation using fluorescent reporters and RNA-seq approaches. Aim 2 will
define the mechanisms for subversion of host nutritional immunity by Ngo TdTs, employing structural biology
and protein-protein interaction techniques. Aim 3 will elucidate the consequences of inhibiting the biological
functions of the TdTs in vitro and with host cells. These studies will test monoclonal antibodies, TdT mutagenesis
and S100 protein inhibitors for impacts on host cell survival and metal uptake. Overall, these innovative studies
will build on exciting findings from the prior funding period and will also move into innovative new areas of
investigation, deploying state-of-the-art technologies. The proposed studies will shed new light on fundamental
pathogenic mechanisms used by Ngo to overcome nutritional immunity imposed by the human host.

Public health relevance
Neisseria gonorrhoeae causes the common STI gonorrhea, for which there are dwindling treatment options and no protective vaccine. N. gonorrhoeae has the striking ability to co-opt human metal-binding proteins, normally meant to restrict bacterial growth, as a source of essential metals. This project seeks to understand the structure and function relationships in four outer membrane transporters produced by N. gonorrhoeae during infection of relevant host cells, to determine the metal environment sensed by N. gonorrhoeae during infection of these cells, and to explore whether inhibitory compounds or monoclonal antibodies block these critical metal acquisition functions, which can point to new therapies against this common infectious disease.